Conference on Implantable Auditory Prostheses

ABSTRACT
This application seeks partial support for the 2023, 2025, and 2027 Conferences on Implantable Auditory
Prostheses (CIAP). The 2023 CIAP is scheduled to be held at the Granlibakken Conference Center, Lake Tahoe,
CA, July 9-14, 2023. The cochlear implant (CI) is the first neural prosthesis in widespread clinical application for
restoring sound sensation and speech understanding to the severely hard-of-hearing population who have
difficulties understanding speech with acoustic hearing aids. Over the past 30 years, dramatic improvements in
patients' performance with these devices have been achieved and hence a wider population of patients can
benefit from cochlear implants. Currently the average speech understanding score for implanted postlingually
deafened adults is nearly 80% correct for sentence recognition in quiet and 50% correct in low levels of
background noise. Congenitally deaf children who receive a CI prior to age 2 are achieving nearly normal rates
of speech and language development. CIs can even provide significant improvement in communication for adults
who have substantial residual acoustic hearing. These advances have benefitted considerably from the collective
efforts of researchers in a broad array of scientific disciplines, from cellular biology, physiology, materials science,
and signal processing, to linguistics and cognition. This interdisciplinary collaboration and cooperation has been
fostered in large part through a series of biennial conferences, originating with a 1983 Gordon Conference. These
conferences are the only forum related to CIs in which scientific research issues are the sole focus of active
participants in the auditory community who contribute to moving the field forward. Even the best CI users though
face significant limitations in music perception as well as speech perception in challenging listening
environments. The long-term goal of CIAP is to generate cutting-edge research ideas to improve the design and
function of auditory prostheses. The Specific Aims are to provide (1) a global forum for the presentation and
discussion of the latest and highest quality research, (2) an atmosphere that is conducive to: disseminating new
findings through scientific discussion, stimulating new lines of research, and facilitating collaborations through
social networking, and (3) an opportunity for young investigators and many trainees in the field to present their
work and network with established investigators. CIAP conferences use the Gordon Research Conference model
of organization, with ample time for discussion within the program, unstructured time to encourage spontaneous
informal discussions and brainstorming, and an isolated “retreat” location where participants spend most of their
waking hours with other conference participants.

Public health relevance
Project Narrative: This proposal seeks partial support for a biennial international conference on basic research on cochlear implants and other forms of prosthetic hearing. This conference provides a unique forum for scientists and engineers to share their latest work and brainstorm about future promising directions in research.